REGULATION OF TRANSCRIPTS INVOLVED IN HUMAN ES CELL DIFFERENTIATION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. We are analyzing pluripotent and neural human embryonic stem cells to determine changes in transcript abundances for the entire list of 800 glycan-related genes.